Mechanism of Microtubule Dynamics Regulation by Kinesins

Kinesins are eukaryotic cytoskeletal proteins best known for their motile activity, but they are also
important regulators of microtubule dynamics, the ability of the microtubule polymer to grow or
shrink. This project seeks to establish the molecular mechanisms and adaptations that allows
different members of the kinesin superfamily to move along microtubules or to modulate
microtubule dynamics. Regulation of microtubule dynamics by kinesins play important roles in a
variety of cell processes such as mitosis, cytokinesis, neural development and the control of cilia
and centriole length, but the mechanisms by which these kinesins stabilize or destabilize
microtubules is still not fully clear. It is also not clear what conformational changes kinesins induce
on the microtubule and whether these conformational changes are transmitted through the
microtubule to allosterically modulate the binding of kinesin and other proteins along microtubules.
To address these questions, we will perform cryo-electron microscopy structural and functional
studies of motile and microtubule depolymerase kinesins, and their effect on microtubule
structure. The proposal is divided into three aims: 1) Determine the allosteric effects of kinesin
binding on microtubule structure and function. 2) Determine the mechanism of combined motile
and microtubule depolymerization activities of Kinesin-8s. 3) Determine the origin of different
functionalities among microtubule depolymerase kinesins.

Public health relevance
The proposed work will investigate the molecular structure and mechanism of action of a group of kinesin proteins that modulate the ability of the microtubular cytoskeleton to elongate and shrink. Due to the role that these kinesins have in cell division and tumor growth they are also attractive targets for the development of anti-cancer drugs. Thus, the proposed studies may help the rational design of a new generation of drugs to treat cancer and human diseases associated with kinesin malfunction (kinesinopathies).